A splice blocking anti-sense oligonucleotide as a novel therapy for US Veterans with hypertension and heart failure (HFpEF)

Over the past decade splice-blocking anti-sense oligonucleotides (SBASO) have been developed and approved
for the treatment of uncommon human genetic diseases. This proposal describes a pilot study to validate the
novel approach of SBASO against a novel target, myosin phosphatase (MP), as a novel therapy for US Veterans
with hypertension (HTN) and its sequelae heart failure with preserved ejection fraction (HFpEF). HTN affects up
to one-half of US Veterans and despite available therapies is still not optimally controlled in ~50%, accounting
for much cardiovascular morbidity and mortality. HFpEF is increasing in prevalence but only a single therapy
was recently shown to be modestly effective. MP by de-phosphorylating myosin causes vascular smooth muscle
(VSM) relaxation; it is also the target of and integrates upstream vaso-dilator/constrictor signals thereby setting
vascular tone and controlling blood pressure (BP). MP regulatory subunit Mypt1 has an alternative exon (E24) that tunes
vascular smooth muscle sensitivity (VSM) to vasodilators (NO, ANP) signaling through cGMP. Skipping
(exclusion) of E24 from mature Mypt1 mRNA codes for an isoform containing a C-terminal leucine zipper (LZ)
motif required for cGMP-dependent kinase (PKG1 activation of MP and vasorelaxation. Inclusion of 31 nt E24
into mature Mypt1 mRNA shifts the reading frame and thus encodes an isoform of Mypt1 lacking the C-terminal
LZ motif. This isoform of MP is not activated by cGMP. In small arteries of rodents and humans ~20-40% of the
MP pool is the E24-/LZ+ isoform activated by cGMP signaling. HTN and HFpEF are driven by an imbalance of
constrictor vs dilator signals resulting in increased systemic vascular resistance to blood flow. Here we propose
to test the novel approach of treatment with SBASO to specifically suppress splicing of E24, thereby shifting
expression to the naturally occurring Mypt1 E24-/LZ+ Mypt1 isoform. This will (re)-sensitize blood vessels to
endogenous vasodilator signals (NO/ANP/cGMP) consequently lowering BP and improving blood flow in HTN
and HFPEF. In proof-of-principle experiments we used the non-translatable Cre-Lox approach to achieve the
same effect - this reduced BP in the AngII/ high salt model of HTN. Here we will test SBASOE24 against the
same target. Preliminary data shows that injection of SBASOE24 is effective in suppression of E24 splicing and
the hypertensive response to AngII. Experiments proposed here will validate efficacy of SBASOE24 in mouse
models of HTN/HFpEF thus de-risking this product for further clinical and commercial development.
Aim 1 will define the dose-response and kinetics of SBASOE24 in normal mice
Mice will be administered: a) SBASOE24 over a 100-fold dose range and inhibition of the target measured by
PCR/qPCR and Western blot; and b) administered the effective dose of 12.5 mg/kg qod x 3 and time to recovery
to baseline of Mypt1 E24+/LZ- isoform measured over the ensuing weeks-months.
Aim 2 will test SBASOE24 in the slow pressor AngII/ high salt (HS) diet model of hypertension
Mice will be administered SBASOE24 at the established effective dose of 12.5 mg/kg qod while receiving AngII
by Alzet osmotic mini-pump and HS diet. Primary endpoints are changes in blood pressure (BP) and Mypt1
isoforms; secondary endpoints include vascular function, inflammatory markers, and blood chemistries.
Aim 3 will test SBASOE24 in mouse models of HFpEF
Male and female mice will be subject to the 3-hit model of advanced age, obesity and hypertension to induce
HFpEF, and then treated with SBASOE24. Primary readouts include BP and indices of heart failure: treadmill
run time and echocardiographic parameters of diastolic function. Secondary endpoints are as in Aim 2.
This SBASO gene therapy could have significant advantages over current approaches for treating HTN/HFpEF:
precision targeting of a specific defect, effect at a terminal effector of multiple upstream signaling pathways, and
prolonged effect simplifying dosing and improving compliance. This novel SBASOE24 therapy could improve
and prolong the lives of the many US Veterans living with HTN/HFpEF.

Public health relevance
High blood pressure - Hypertension (HTN) - and its sequelae heart failure (HFpEF) are common in US Veterans. Neither are optimally treated with current medicines. This proposal will test a novel therapy in animal models of HTN and HFpEF. The novel therapy is a conjugated anti-sense oligonucleotide (ASO). In the past few years, ASO and similar biologicals have been approved for the treatment of uncommon genetic diseases and most recently high cholesterol. Here we test an ASO that causes a shift in naturally occurring enzyme isoforms in blood vessel smooth muscle cells. It is predicted to make them more sensitive to the signals that dilate the blood vessel; thereby, lowering blood pressure and improving blood flow and ameliorating symptoms of heart failure. Advantages over current therapies could include greater potency by influencing multiple signlaing pathways, and prolonged duration of effect enabling infrequent treatment and improved patient compliance. If successful this novel gene therapy could improve and prolong the lives of the many US Veterans living with HTN and HFpEF.